Biophysical regulation of macrophage function

PROJECT SUMMARY
Macrophages are central regulators of inflammation and tissue healing following injury or
infection, and during disease. While much is known about how soluble, biochemical factors in the
environment regulate macrophage function, less is known about how biophysical cues regulate
their response, despite the fact that these cells exist within solid tissues that are rich in mechanical
cues. Furthermore, many diseases in which macrophages are involved, such as cancer and
fibrosis, are characterized by changes in tissue biophysical properties. Our previous work
demonstrated that adhesion to soft extracellular matrix hydrogels inhibits macrophage
inflammatory activation. In preliminary work, we found that matrix rigidity influences the
localization of YAP, a transcriptional co-factor involved in cell proliferation, organ size control, and
cancer, but with previously undescribed role in macrophage activation. Adhesion to stiff
substrates leads to YAP nuclear localization, which appears to prime macrophages for a potent
inflammatory response. In addition, cytoskeletal polymerization and the mechanically-activated
and calcium-permeable ion channel Piezo1 appear to be involved in YAP nuclear localization and
inflammatory activation. In this study, we propose to investigate the molecular mechanisms
underlying YAP signaling and Piezo1 activity in the macrophage response within different stiffness
environments. In Aim 1, we will examine the effect of stiffness on cytoskeletal remodeling and
associated signaling pathways on YAP activity. In Aim 2, we will probe the role of Piezo1-mediated
calcium activity in stiffness sensing, YAP signaling, and macrophage function. Finally, in Aim 3,
we will investigate the role of YAP and Piezo1 on macrophage-mediated wound healing in vivo
using a murine subcutaneous biomaterial implant model. An improved fundamental
understanding of how macrophages sense their mechanical environment may lead to new
immunomodulatory strategies that control macrophage function during disease.

Public health relevance
PROJECT NARRATIVE Macrophages are central regulators of inflammation and tissue repair processes, and their function is tightly controlled by cues in the surrounding microenvironment. The goal of the proposed research is to elucidate the molecular mechanisms underlying how tissue stiffness controls macrophage function. This work may open new strategies to modulate immune function during wound healing and disease.